CGMP-MEDIATED VASODILATION IN PERINATAL LUNG

DESCRIPTION: In vascular smooth muscle cells, endothelium-derived NO, ANF, nitrovasodilators and exogenous NO-induced vasodilation by activation of the PKG cascade following increases in intracellular cGMP concentrations. The NO-cGMP-PKG pathway plays a pivotal role in establishing low vascular resistance in the pulmonary circulation. The applicant and others have been studying this pathway and thus far has focused on studies of the enzymes (guanylyl cyclase and phosphodiesterase) that regulate cGMP levels. Studies ar now proposed to determine the mechanisms by which elevated cGMP in vascular smooth muscle cells ultimately result in vasodilation in the developing lung a the time of birth. Aim 1 will determine the role of PKG in cGMP-mediated vasodilation and the link between the developmental increase in cGMP-induced dilation in the perinatal period and PKG activity will be explored. The specific roles of PKG type 1-alpha and 1-beta isoforms will be determined. Aim 2 will determine the role of the protein phosphatases, PP1 PP2A, and PP2B, in PKG-mediated vasodilation. Aim 3 will determine the effect of oxygen tension o PKG and phosphatase activity in the perinatal period. All studies will be conducted in the ovine species, and isolated vessel tension experiments will b complemented with molecular and biochemical studies in the experimental protocols. The investigators have shown that responses of pulmonary arteries may be quite different from those of veins, and experiments will therefore be done in both arteries and veins. Any disturbance in the normal fall in pulmonary vascular resistance at birth results in pulmonary hypertension of th newborn and significant morbidity and mortality. Knowledge derived from these studies could lead to a better understanding of the mechanisms of pulmonary vasodilation at birth and thus to develop strategies to prevent and treat pulmonary hypertension in the perinatal period.